Development of a gene edited platform to enable human allogeneic cell replacement therapy

SUMMARY
Stem cell-based therapies have the potential to regenerate cells, tissues, and organs damaged by injury,
age, and autoimmunity. Pluripotent stem cell (PSC)-based clinical trials have begun in which retinal pigmental
epithelial cells, dopaminergic neurons, and insulin-producing beta cells are used to treat macular degeneration,
Parkinson’s disease, and type 1 diabetes (T1D), respectively. The initial results have been quite promising, and
clearly the future of this avenue of investigation and treatment is bright. The case for using this approach to treat
T1D is perhaps the strongest, given that mature beta cell transplants from cadavers have long been shown to
be curative, and initial PSC-derived beta cell transplants have also led to independence from exogenous insulin.
Aleutian Therapeutics is focused on this line of treatment for curing T1D. Nonetheless, there are major barriers
to be overcome to make these types of PSC-based therapies practical and accessible. Autologous iPSC-based
approaches, for instance, are costly and unscalable. Allogeneic PSC-based approaches, on the other hand,
require administration of toxic immunosuppressive drugs to avoid destruction of transplanted cells by the host
immune system.
To overcome these limitations, Aleutian Therapeutics (Aleutian) is developing a novel gene editing-based
platform to enable allogeneic PSCs and their progeny to evade recognition by the host immune system.
Aleutian’s innovative approach has successfully demonstrated survival of PSC grafts in mice with a fully
functional immune system. In contrast, others developing similar technologies have relied on in vitro studies or
humanized mice, which may not represent the complexity of a native immune system. In fact, Aleutian’s
technology has been shown to enable human PSC to survive for nearly 6 months in immunocompetent mice,
effectively overcoming the xenogeneic barrier, often regarded as even higher than the allogeneic barrier. Having
used this approach to successfully identify the key immune recognition pathways that must be evaded, the goals
of this Phase 1 study are to now 1) adapt our system in which mouse immune evasion genes are swapped with
the functionally equivalent human orthologs; 2) define the minimum required combinations of these human
immune evasion factors through functional assays; 3) confirm that these edits do not impact beta cell
differentiation and allow beta cells to evade the key arms of the host immune system. Successful completion of
this study will inform the design and generation of a CRISPR-Cas9 edited cell line that can be further evaluated
in in vivo pre-clinical studies during a Phase II program.

Public health relevance
NARRATIVE The development of immune-evasive stem cells through gene editing has significant implications for healthcare by expanding access and reducing risks associated with therapeutic cell transplants. Cell therapies have demonstrated success in autoimmune disease, Type 1 diabetes, cancer, among others, but current technologies suffer from unscalable manufacturing, poor durability, or a requirement to administer toxic immune suppression drugs. Aleutian is developing a panel of genetic edits in stem cells that have the potential to enable scalable manufacture of universal donor cells and administration of these cells for therapeutic applications without the need for immunosuppressive drugs.